International Society for the Study of Hypertension in Pregnancy (ISSHP) World Congress

DESCRIPTION (provided by applicant): The purpose of this proposal is to convene an internationally recognized multidisciplinary group of investigators to present and discuss current research findings in the area of preecampsia or hypertension in pregnancy.

Public health relevance
PUBLIC HEALTH RELEVANCE: The purpose of this proposal is to convene an internationally recognized multidisciplinary group of investigators to present and discuss current research findings in the area of preecampsia or hypertension in pregnancy.